Single-cell phenotyping for better drug discovery

Abstract
Mycobacterium tuberculosis (Mtb) infects nearly 10 million people yearly and kills almost 1.5 million. Treating
even drug-susceptible tuberculosis (TB) is difficult because subpopulations of bacteria, while not genetically
resistant, can evade killing by antibiotics. To discover small molecule inhibitors for these tolerant
subpopulations, we need to understand where they are located and what is their physiology. Directly identifying
tolerant bacteria is impossible with conventional methods that rely on measurements from millions or billions
of cells. Here, to overcome these limitations we have assembled a team with expertise in single-cell
measurements, live-cell microscopy, and TB pathogenesis and metabolism. Leveraging these skills, we have
succeeded in quantifying the growth and metabolism of individual mycobacteria in different subcellular
environments. We propose to build upon these results and establish which subcellular environment is most
associated with drug tolerance, and what carbon source is used by drug-tolerant M. tuberculosis. Then, we will
design in vitro culture conditions mimicking this environment. These culture conditions will be used in future
drug screening efforts designed to find small molecule inhibitors of drug tolerant mycobacteria.

Public health relevance
Project Narrative Leveraging single-cell reporters for mycobacterial growth and metabolism and live-cell microscopy, we will determine what intracellular environment is most associated with drug tolerance of the pathogen. Then, we will design in vitro culture conditions that replicate this environment. These conditions could be used in drug screening efforts to find small molecule inhibitors targeting slow-growing and drug-tolerant subpopulations of mycobacteria.